Allosteric Modulation of PAR1 for the Treatment of Sickle Cell Disease

PROJECT SUMMARY
This proposal describes the investigation of a new class of antithrombotic and anti-inflammatory small
molecules called parmodulins for the treatment of sickle cell disease (SCD). SCD is a group of related
disorders caused by mutations in the β-globin subunit of hemoglobin that leads to polymerization of
hemoglobin and the distortion of red blood cells, initiating a range of dangerous effects. In particular, SCD
patients suffer from debilitating vaso-occlusive crises (VOCs), which involve the trapping of “sickled” red blood
cells in small blood vessels and subsequent thrombotic and inflammatory responses that are painful and
dangerous. Despite the approval of several new SCD therapies in recent years, drugs that can drastically
decrease the frequency and severity of VOCs have yet to be identified. Parmodulins are allosteric modulators
of protease-activated receptor 1 (PAR1), and have demonstrated the ability to inhibit the activation of both
platelets and endothelial cells driven by the coagulation enzyme thrombin under inflammatory conditions
(thrombo-inflammation). In a partnership between Function Therapeutics and the lab of Dr. Erica
Sparkenbaugh (Univ. of North Carolina, co-investigator), certain parmodulins have already demonstrated
efficacy in mouse models of SCD. Building upon these results, this Phase 1 project will identify parmodulins
with improved potency and oral activity and confirm their efficacy in mouse models of SCD, including the
administration of hemin to mimic the potentially deadly acute chest syndrome in SCD patients. A modest
medicinal chemistry (lead optimization) program will be undertaken, followed by a sequence of established in
vitro assays to identify the most promising parmodulins. This will be complemented by pharmacokinetic (PK)
studies to identify bioavailable examples most suitable for oral dosing.
Specific Aims: 1. Synthesize novel parmodulins with selective, nanomolar activity at PAR1, and properties
consistent with chronic oral dosing. 2. Identify orally active lead parmodulins and confirm their antithrombotic
and anti-inflammatory activities. 3. Confirm in vivo activity of optimal parmodulins in mouse models of SCD.
In addition to confirming that orally active parmodulins for the treatment of SCD are feasible, this project will
establish PK/PD relationships and early dose-responses. Successful results will justify additional safety and
efficacy studies in a future preclinical development phase, which could lead to a new therapy for the prevention
of VOCs in SCD, and possibly for other thrombo-inflammation-related disorders.

Public health relevance
PROJECT NARRATIVE Sickle cell disease is a genetic disorder that causes misshapen (“sickled”) red blood cells and affects millions worldwide. It causes a range of dangerous effects, including painful blockages of blood vessels (called vaso- occlusive crises) that are not well addressed by current medications. In this project, examples of a promising new class of antithrombotic and anti-inflammatory molecules called parmodulins will be prepared and tested in cell assays and mouse models of sickle cell disease and vaso-occlusive crisis.